MOLECULAR MECHANISM IN TYPE III GLYCOGEN STORAGE DISEASE

The purpose of this study is to investigate 1) the effects of various dietary treatments on disease progression in the glycogen storage diseases (GSD), 2) the molecular basis and genotype-phenotype correlations of glycogen storage disease, 3) the mechanism and treatment of renal disease associated with type I GSD, and 4) development of recombinant enzyme replacement therapy for GSD type II.